Core B: Biospecimen and Pathology Resources Core

Project Summary
The aims of the Biospecimen and Pathology Resources (BPR) Core (Core B) are to facilitate the storage and
distribution of comprehensively annotated, high-quality biospecimens and their derivatives, and to provide
professional and technical pathology services to the principal investigators and collaborators of our SPORE and
Kidney Cancer Program. All three SPORE projects utilize Core B, which is critical to achieving their aims. It is
an indispensable component of our SPORE and leverages and expands (without duplicating) existing pathology
resources in our National Cancer Institute (NCI)-designated Simmons Comprehensive Cancer Center. We
deliver basic histology, immunohistochemistry (IHC), in situ hybridization (ISH), tissue microarrays, whole slide
imaging, image analysis, and laser-capture microdissection services, and make available unique cancer tissue
derivatives such as primary cancer cell cultures and cell lines, cryopreserved tissues, DNA, RNA, and patient-
derived xenografts (PDX or tumorgrafts, TG). These efforts are complemented by several national initiatives led
by the Core. This Core provides expertise in histomorphologic evaluation of human kidney tumors, human
tumorgrafts in mice, kidney tumors in transgenic and knockout animal models, and in the interpretation of IHC
and ISH and multiplex immunoassays. The BPR Core develops IHC and molecular assays and has experience
in the deployment of CLIA-certified laboratory tests, such as our PD-L1 IHC. The BPR Core currently has fresh-
frozen renal tumor and paired-normal kidney (or blood) tissues for >1,700 racially and ethnically diverse patients;
a unique live-tissue repository of >1,900 kidney tumor tissues preserved viable in DMSO for mechanistic studies
to address questions arising from genomic and other studies of inert tissues; >200 independent TG lines; 47
primary tumor cell lines representing a wide variety of tumors; and integrated genomic analyses (exome
sequencing, RNA-Seq and SNP arrays) of >500 RCC patients. Specimen data is linked to the institutional tissue
bank, and to comprehensive patient clinical data through Kidney Cancer Explorer (Core C). The BPR Core
provides routine quality control for SPORE investigators to ensure that the tissues are optimal, and several of
our protocols have been published in Nature Protocols and serve as benchmarks in the fields of tissue processing
for integrated genomic analyses and TG utilization for preclinical drug testing. Our repository has had significant
utilization, with >1,000 samples having been shipped to collaborators both internally, as well as externally. TGs
have been extensively utilized to evaluate RCC drug sensitivity, study radiation responsiveness, explore tumor
biomarkers, understand cancer biology (including rare syndromes), and dissect metabolic derangements in
RCC. Studies with these tissues have been published in high-impact journals such as Nature Genetics, Nature
Communications, and Lancet Oncology. Our Core promotes flourishing collaborations among our SPORE
investigators, investigators from other SPOREs, and other investigators in academia and industry.

Public health relevance
Project Narrative All of the proposed SPORE projects are dependent on the pathology and tissue resources provided by the Biospecimen and Pathology Resources Core (Core B). The Core B Director is a pathologist with histomorphologic and research expertise in adult kidney cancers, and with extensive experience in biobanking. The proposed Core infrastructure will further strengthen our ongoing translational mission and has the potential to revolutionize personalized medicine in renal cancer.